Ambient Outdoor Heat and Alzheimer's Disease and Related Dementias Risk: A Biopsychosocial Approach to Vulnerability in Older Adults

PROJECT SUMMARY
The objective of this K99/R00 proposal is to facilitate Dr. Choi to establish an independent and specialized
research program on climate hazards and the risk of Alzheimer’s Disease and Related Dementias (ADRD).
The frequency, intensity, and duration of extreme heat events are expected to grow rapidly in the coming
decades, affecting over 100 million Americans in 2050. High temperatures may pose significant hazards for
cognitive and brain health. Yet, the precise nature and magnitude of extreme heat-induced ADRD risks remain
unclear, particularly among a diverse older population. This project aims to fill this gap by providing Dr. Choi
with strong content and methodological expertise in the social vulnerability approach to heat and
neurobiological underpinnings to determine if high outdoor temperatures increase ADRD risks and to assess
how socioeconomic and environmental factors at personal and community levels modify these risks. This
project merges longitudinal daily climate records with neighborhood contextual data and the nationally
representative and diverse Health and Retirement Study of U.S. adults aged 50, which has collected decades
of data on cognitive function, dementia, social factors, and recently, neuropathological biomarkers. In the K99
phase, four training objectives support Dr. Choi’s transition into a leading interdisciplinary investigator who
drives substantive questions on how climate hazards affect cognitive health and dementia risk. First, she will
develop expertise in heat exposure assessment and the social vulnerability approach. Second, she will acquire
knowledge of the biological underpinnings of neurodegeneration and blood-based AD biomarkers. Third, she
will cultivate proficiency in advanced longitudinal and mixture analyses to model dynamics across heat and
vulnerability factors. Fourth, she will pursue professional development opportunities to establish independence
and leadership. This set of training will prepare her to achieve three research aims. Aim 1 determines how
outdoor high temperatures contribute to cognitive decline and dementia risk. Aim 2 examines the effect
modification by, or joint effects with, neighborhood and individual-level multidimensional vulnerability factors
that exacerbate the cognitive risks induced by heat based on advanced epidemiological models. Aim 2
examines the association of extreme heat with blood-based AD neuropathological markers. Dr. Choi proposes
to pursue these training goals and begin the proposed research within the Davis School of Gerontology at the
University of Southern California, an ideal environment with abundant intellectual and structural resources,
training opportunities, and interdisciplinary researchers in ADRD, environmental health, and the biology of
aging. This project works towards reducing emerging climate hazards for ADRD risk by elucidating the
neurobiological and social pathways leading to individual differences in neurocognitive risks from neighborhood
climate environments. It aligns with the NIA’s goal to address the exposome in ADRD and offers new insights
into multi-level intervention strategies to mitigate risk among the most vulnerable populations.

Public health relevance
PROJECT NARRATIVE There is a growing concern that extreme heat may pose significant hazards for the cognitive and brain health of an aging population. This project seeks to establish the extent to which outdoor high temperatures increase the risks of Alzheimer’s Disease and Related Dementias (ADRD), measured by neuropathological changes, cognitive decline, and dementia onset, and to assess how various economic, social, and environmental factors at personal and community levels modify these risks. The knowledge generated from this project will have significant relevance for public health efforts, including the NIA’s Interest in Exposome Research, to develop precision environmental health strategies for ADRD risk reduction and disease prevention that would improve healthy brain aging across the diverse U.S. older adult population.